Administration

ADMINISTRATION - PROJECT SUMMARY/ABSTRACT
Montefiore Einstein Comprehensive Cancer Center (MECCC) Administration provides efficient and innovative centralized administration, analytics and programmatic infrastructure that enables exceptional basic, translational, clinical and population-based research at MECCC. Administration partners with, and serves, MECCC senior leadership to foster scientific collaboration, implement strategic planning and evaluation efforts, create and disseminate membership tools and metrics, staff leadership meetings and retreats, coordinate and manage pilot project competitions, recruit and onboard new investigators, and manage and report on investments and all MECCC accounts, ensuring compliance with all institutional policies and federal requirements. Administration facilitates rigorous cancer-related research operations and administration, community outreach and engagement, catchment area research, and cancer research training and education to carry out MECCC’s mission to “reduce the burden of cancer in the Bronx and the nation through our cancer-focused research, education and training, and community outreach and engagement with delivery of compassionate care for all, including communities that face heightened challenges with respect to cancer.” MECCC Administration staffs all internal and external planning and evaluation efforts, develops policies and processes to manage membership and all corresponding metrics and tracking, has shared oversight of shared resources with the Dean’s Office at the Albert Einstein College of Medicine (Einstein), supports the Director in all faculty recruitment, administers and tracks pilot projects and other internal research awards, has shared oversight of space and facilities, oversees communications, marketing and the MECCC website, and is staff to Senior Leadership Team and Research Leadership Council meetings and all MECCC scientific retreats. Administration has direct oversight for all MECC budgets and finance, space, facilities and equipment, human resources, philanthropy, and clinical trials and clinical research operations.
Administration’s success is demonstrated through the extensive work with Senior Leadership to develop and implement a rigorous planning and evaluation process to support the MECCC Strategic Plan 2021-2026, inclusive of staffing eight Strategic Working Groups with tools to track progress; manage the exceptional institutional investment to realize goals, support analytics and strategic decision making for the new research program structure, align and implement new shared resource collaborations, launch a new, integrated website for the MECCC and create a new Membership Dashboard and online administrative tools to manage membership, pilot projects and CCSG metrics.

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Chu, Edward CANCER CENTER ADMINISTRATION - PROJECT NARRATIVE Per PAR-21-321, a Project Narrative is not required for this Component. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page